The Impact of 9/11 on Youth: Mental Health, Substance Use & Other Risk Behaviors

DESCRIPTION (provided by applicant): The purpose of this investigation is to improve understanding of the effects of children's direct exposure to 9/11 and future mental health disorders, substance use or abuse and other risky behaviors as they now enter into adolescence and emerging adulthood. Based on the behavioral development literature, our city-wide assessment of children 6 months after 9/11 and the numerous findings of post- 9/11 consequences amidst exposed adults, there is strong evidence to suggest that exposure to 9/11 early in life would increase directly exposed children's vulnerability within the domains of interet in this investigation. Unfortunately, to date, the science-base of post-disaster behavioral consequences for youth, including those who were 9/11 exposed as children, lacks a longitudinal assessment, that includes in-depth measurement of the multiple, complex relevant domains, from type and severity of exposure to well-defined behavioral outcomes and intrapersonal, familial, academic and environmental factors. The proposed study will assess 1,000 children directly exposed to 9/11 at ages 0-12 and currently ages 12- 24, drawn from the World Trade Center Health Registry (WTCHR) Pediatric sample, who will be compared to unexposed Controls (N=500). The study involves a synergistic collaboration between the Child Psychiatric Epidemiology Group (CPEG) at Columbia University-Research Foundation for Mental Hygiene and the WTCHR. The WTCHR has longitudinal data on this population since 2002-2003, including excellent participant tracking information. CPEG has conducted many large-scale assessments of vulnerable youth, including 9/11 exposed children and their parents, addressing themes of high

Public health relevance
public health relevance. The proposed study will build upon ongoing research, as CPEG has a successful collaboration with the WTCHR, focused on children's whose parents were exposed to 9/11. Using a combination of well-tested epidemiologic methods, augmented by the original consideration of behavioral decision making assessments, findings from this study will fill important knowledge gaps which could significantly reduce the potential burden of lifetime behavioral problems and disabilities, by facilitating diagnosis interventions geared towards 9/11 exposed youth and potentially other disaster exposed populations. Worldwide Public Health concern about disaster and its long-term consequences on mental health remains an important but inadequately addressed issue. This proposed study of the outcomes for children directly exposed to the 9/11 attack, by assessing their current (ages 12-24) mental health, substance use and other risky behaviors, including the role of decision-making, is designed to obtain an-in depth assessment of these adolescents' and emerging adults' current level of need, with the intention of facilitating treatment, diagnosis and intervention, as well as to inform public policy. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Introduction: The World Trade Center Health Registry (WTCHR) Pediatric sample133 provides an unparalleled opportunity for understanding the long-term effects of the 9/11 attack on exposed children. As residents of the World Trade Center area and as students in local schools, children experienced a wide range of exposures. While strong evidence exists linking early trauma exposure with a wide range of adult psychiatric disorders56,83,96, much less is known about the behavioral (mental health, substance abuse and other high-risk behavior) consequences of disaster on adolescents and emerging adults who were exposed to trauma during childhood. Based on the WTCHR findings among adults31,45, we expect youth directly exposed to 9/11 will also be at high risk of presenting with PTSD11,31,86,106. Also, based on the literature, we anticipate that this particular trauma early in life will increase vulnerability to other anxiety disorders, depression, use of substances and other high-risk behaviors frequent in adolescence, such as unprotected sex and injuries14,134. Adolescence and emerging adulthood are malleable periods during which behavioral problems are prevalent but also could be prevented or attenuated, if better information was available to guide action51,58,69,72. For example, during adolescence the use of substances, even heavy use, is not uncommon107. While this often evolves into substance abuse or dependence, with proper intervention, it may remit. Another example is injury (e.g. vehicular accidents) the leading cause of death in this age group10. By understanding how direct exposure to 9/11 may have increased a wide range of behavioral problems and other poor outcomes in adolescents and emerging young adults, we can become better prepared to intervene during this high-risk, high-yield period. Such interventions would have significant consequences for reducing the burden of lifetime disorder and disability, while also minimizing the economic consequences to society. The science-base of post-disaster behavioral responses by youth, however, currently suffers from a nearly complete absence of longitudinal information62. In-depth longitudinal measurement of complex constructs in this population, such as proposed here, has simply not been possible until now. We propose, therefore, to conduct a thorough assessment of the WTCHR Pediatric sample, which will fill important knowledge gaps, resulting in valuable information to guide care for those exposed to 9/11 as children, while simultaneously providing new information relevant for youth exposed to other traumatic events, most especially mass-trauma or disaster. The proposed study of N=1,000 children exposed to 9/11 and N=500 unexposed Controls, ages 12 - 24, will be implemented through collaboration between the Child Psychiatric Epidemiology Group (CPEG) at Columbia University-Research Foundation for Mental Hygiene (PI: Hoven) and the WTCHR. The WTCHR has excellent tracking information on this population and the CPEG is familiar with this population and has conducted many other successful large-scale assessments of vulnerable youth, addressing themes of high public health relevance1,8. This work includes the NYC Department of Education epidemiological study of a representative sample of 8,236 public school children in NYC conducted six months after 9/1137,62-65,68,70,71,145. The proposed study will build upon an ongoing (close to completion) study, a collaboration with the WTCHR focused on assessing the developmental course of behavioral problems of children whose parents were exposed to 9/11 (WTC Parent Exposure - Youth Study; R01 HD046786; PI: Hoven)66. That study used a methodology that is similar in many ways to that which will be used with the children directly exposed to 9/11 (at ages 0-11) in the proposed WTC Directly Exposed Youth Study or DEY Study (DEYS). Specific Aims: Aim 1. Determine the prevalence of mental disorders (anxiety disorders and major depression), substance use/abuse (nicotine, alcohol, marijuana, other illicit/prescription drugs) and other high-risk behaviors (sexual and injury risk behaviors) by age, gender and race/ethnicity among adolescents and emerging adults highly exposed to 9/11 as children. Aim 2. Examine if exposure to 9/11 during childhood (closeness to WTC epicenter, physically hurt and/or witnessed disturbing events, parental exposure) is related to risk of mental disorders, substance use/abuse and other high-risk behaviors during adolescence and emerging adulthood. Aim 3. Inform diagnosis and treatment of youth exposed to the WTC attack by identifying factors that can indicate risk and examine mechanisms through which childhood exposure to 9/11 may impact adolescents' and emerging adults' outcomes (mental disorders, substance use/abuse and other high-risk behaviors); specifically, (a) Patterns of behavioral decision making (propensity for risk-taking and regulation of impulsivity); and (b) Attack related life changes (family economic hardship, school/residence relocation, safety/preparedness procedures).